Investing in Research Software Engineering for Expert Development and Dissemination of Bioconductor

This grant aims to support the career development of Lori Kern, a central developer of several
facets of the NIH/NHGRI/NCI funded Bioconductor project: an open-source, open-development
software project that develops, supports, and distributes software for genetic and genomic
research, analysis, discovery and visualization. It will invest in the Research Software Engineer’s
identified project goals to enhance and improve development and dissemination of Bioconductor.
These goals include: Goal 1: Upgraded support for global computational genomic data science.
This involves enhancing Bioconductor’s process for curating, documenting, and distributing
Findable, Accessible, Interoperable and Reusable for Research Software (FAIR4RS) data and
annotation for use in computational genomic data science. Experiment data, genomic reference
information, and analytic algorithms are combined to produce statistical interpretations of novel
experimental findings. Bioconductor strives to provide high quality data and up-to-date genomic
annotations either through Bioconductor Hubs that reference remotely available data for
download or traditional Bioconductor R packages. There are currently 71787 annotation
resources from 2994 species available for download from the current AnnotationHub, 8332
Experiment data resources available in ExperimentHub, 926 standard Annotation Packages, and
430 standard Experiment Packages available in Bioconductor. Refinement and evaluation of
currently available resources to ensure accuracy and relevance, and providing easier direct
access in Bioconductor/R to other existing relevant genomic reference information, is essential
for researchers to achieve novel experimental findings. Goal 2: Personal skill development that
will enhance the sustainability of Bioconductor, with particular attention to concepts of cloud-scale
research software, data, and genomic annotation production, management, and distribution as
well as integration and collaboration with other relevant biological and bioinformatic communities.
Goal 3: Project and Community leadership strengthening. Bioconductor leverages its extensive
community to contribute and propel the project forward. With over 1192 active community
developers, wrangling a highly technical and evolving ecosystem becomes vital. A balance of
integrating cutting-edge, new technology and methodology with reliability and efficiency becomes
essential to Bioconductor sustainability and relevance. Enhancements to the contribution process
and learning opportunities for the community will help reach and connect the thousands of
developers and millions of users. The outcomes will strengthen the well-established impact of
Bioconductor in genome research in academia and industry.

Public health relevance
PROJECT NARRATIVE This grant aims to support Lori Kern, a senior developer of the NIH/NHGRI/NCI funded Bioconductor project: an open-source, open-development software project that develops, supports, and distributes software for genetic and genomic research, analysis, discovery and visualization. It will invest in the Bioconductor Research Software Engineer’s enhancements and novel developments of Bioconductor infrastructure surrounding software, experimental data, and genomic annotation production and dissemination, scalable strategies and solutions for project sustainability, and engaging and mobilizing the community. The outcomes will strengthen the well- established impact of Bioconductor in genome research in academia and industry.